A novel multifunctional role of diverse substrate binding and import by the Haemophilus Sap transporter

Project Summary
There have been no changes to the Project Summary for the R01 GM140584-01 parent award.

Public health relevance
Project Narrative There have been no changes to the Project Narrative for the R01 GM140584-01 parent award.